DAPSONE AND ATOVAQUONE FOR PROPHYLAXIS AGAINST PCP IN HIV INFECTED PATIENTS

This study will compare the safety and efficacy of dapsone and atovaquone in the prevention of Pneumocystis carinii pneumonia (PCP) in HIV-infected patients who are intolerant of trimethoprim and/or sulfonamides.